Texas Minority Health, Research and Outreach (MiHERO)

Project Summary
The long term objective of the Texas Minority Health, Education, Research and Outreach (Texas MiHERO) is to
expand the capacity of University of North Texas Health Science Center (UNTHSC) to enhance research and
research training in minority health and health disparities by increasing the number of under-represented
students in health disparity research, providing interdisciplinary research and leadership training to junior faculty,
and increasing the number of health professional faculty involved in health disparity research. Given the
substantial need for physicians, physician scientists, and other health professionals to care for vulnerable
populations, and the critical need to study diseases and conditions that disproportionately affect these groups,
more efforts are needed to increase the participation of individuals from diverse backgrounds in conducting
research on minority health and health disparities, and encouraging them to consider careers in research and
related fields. The Texas Center for Health Disparities (TCHD), a NIMHD-Specialized Center of Excellence
developed the MiHERO program, through the NIMHD S21 mechanism, to increase health disparity research
capacity by increasing the size of the PhD workforce in health disparities, train junior faculty in interdisciplinary
research leadership, and provide opportunities for senior investigators to develop research focus in minority
health and health disparities. Four priority activities will be conducted under the MiHERO program:
• Priority Activity 1: Support an Interdisciplinary Research Leadership (IRL) Program for junior faculty in
Minority Health and Health Disparities
• Priority Activity 2: Recruit/Retain diverse faculty through a Health Education, Awareness and Research
in Disparities Scholarship (HEARD Scholars) program in Minority Health and Health Disparities.
• Priority Activity 3: Increase the diversity of the biomedical, behavioral and clinical research workforce by
recruiting a new cohort of PhD students from minority and underrepresented groups each year who focus
on health disparities.
• Priority Activity 4: Develop a mechanism for minority health and health disparity researchers to engage
community members in their research.
Using the endowment funds secured through this mechanism of funding, we will ensure robust training
opportunities are provided that encourage participants of the proposed program to seek careers in research and
related field that address the issue of health disparities. The impact of the endowment income will be sustainable
programs in Minority Health and Health Disparities, including health disparity curricula for PhD students, a junior
faculty development program that can be expanded to faculty from other institutions, and a cadre of health
disparity researchers who have active research projects in the area of Minority Health and Health Disparities.

Public health relevance
Project Narrative The goal of the Texas MiHERO program is to utilize the John Lewis NIMHD Endowment funding to build capacity and infrastructure at the UNTHSC for its nationally recognized health disparities research, training and outreach activities, specifically in recruiting and training more minority faculty and PhD students. Through an innovative interdisciplinary research leaders program, a faculty scholarship program and training PhD students in minority health and health disparities, MiHERO will enable transdisciplinary, interprofessional collaborations and novel approaches to understanding minority health and eliminate health disparities.